The Mechanistic Role of Visual Areas at the Interaction of Social Behavior and Drug Effects in Nonhuman Primates

PROJECT SUMMARY
To control the use of illicit drugs, we must know how they affect the brain in its entirety. Drugs such as MDMA
and methamphetamine influence social emotions, targeting regions associated with emotional and reward
regulation, but their effects on sensory processing remain understudied. This project aims to investigate the
impact of MDMA and methamphetamine on the visual and associative regions of the macaque monkey brain
using electrophysiology and deep neural networks. We will determine how social viewing affects drug-taking
and integration, hypothesizing that positive social stimulation reduces drug-taking impulses and that MDMA
biases prosocial free viewing. Neurons in visual cortex and pulvinar nucleus are predicted to integrate visual
features, influencing visual saliency and attention. Using machine learning, we will visualize features activating
neurons, including those previously considered “non-visual” or semantically uninterpretable. We predict that
neurons processing local features present in conspecifics will show stronger effects during drug administration,
from early visual cortex throughout associative cortex. We will develop an interpretable deep model of vision
accounting for drug effects, using a novel codebase (ATHENA-N) to simulate enhanced connectivity, variability
reduction, and synchronization in cortex. Long-term properties of proto-social and other neurons will be tracked
in multiple visual areas using chronically implanted microelectrode arrays and naturalistic social behavioral
tasks under repeated drug administration. This will assess chronic drug effects and inform future therapies.
Our novel machine learning methods will reveal basic processing of social behavior in various brain regions
and the extent of MDMA and methamphetamine effects on the visual cortex and subcortical structures like the
pulvinar and ventral striatum. This project will demonstrate that sensory region neurons can be selectively
affected by drugs based on their role in social behavior and will provide a fully interpretable mechanistic model
of social visual processing, analyzing image information with and without drugs. This research will advance our
understanding of social cognitive functions in early sensory cortex and their influence by drug use, highlighting
the importance of sensory processing in social interactions and informing potential treatment durations for
chronic drug use.

Public health relevance
PROJECT NARRATIVE This project will investigate the effects of MDMA and methamphetamine on visual and associative brain regions in macaque monkeys, focusing on how these drugs influence social behavior and sensory processing. Using electrophysiology and advanced deep learning models, the research aims to provide insights that could guide future therapies for drug abuse.